Robust Computational and Data Analytic Tools for In-depth Understanding Postoperative Pain Mechanism with Enhanced Pain Management and Clinical Decision Making

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

Public health relevance
This application aims to create robust computational tools for analyzing messy observational data on postoperative pain (POP). These methods will enhance the precision of POP phenotype predictions to achieve timely POP control and reduce the risk of opioid overuse. The project will also investigate causal mechanisms of POP and establish the optimal personalized POP management plans, leading to a deeper understanding of the mechanisms behind POP and improved POP clinical decision-making at both the individual and population levels.